Surgical Multispecialty Access to Research in Residency Training (SMART)

SUMMARY
Surgeon-scientists are an underrepresented population in academic medicine, and federally funded surgeon-
scientist-led research has been in decline over the past decade. Substantial challenges are faced by surgical
residents seeking research training. Importantly, surgical resident training programs with ample protected time
for dedicated, intensive experiential research training have effectively contributed to the “pipeline” of
successful, independently funded surgeon scientists. These researchers have meaningfully impacted surgical
oncology patient care and scientific knowledge. The proposed Surgical Multispecialty Access to Research in
Residency Training (SMART) program brings together the extensive multidisciplinary oncologic expertise at
Northwestern University's Feinberg School of Medicine (NUFSM) and the Robert H. Lurie Comprehensive
Cancer Center to create a multidisciplinary, two-year research training program consisting of (1) a Health
Services and Outcomes Research (HSOR) Track and (2) a Basic Science and Translational (BTS) Research
Track. SMART will draw upon the NUFSM Department of Surgery's 30-year experience of training surgical
residents in bench and translational surgical oncology research and the 15-year surgical oncology HSOR
resident training collaboration between the Northwestern Institute for Comparative Effectiveness Research in
Oncology (NICER-Onc), the HSOR Postdoctoral Fellowship at Northwestern, and the American College of
Surgeons (ACS) Cancer Programs. Since 2009, we have trained 46 surgical research residents who have
gone on to oncology-focused academic careers. During a two-year, intensive training period (90% protected
time), residents in SMART will be immersed in multidisciplinary, experiential research training, using a team
science approach, with committed mentorship and focused didactic teaching, while assuring their eligibility for
certification by the American Board of Surgery. Each trainee will have an experienced and diverse Mentor
Team (content and methodological experts), tailored to their training needs. The SMART core curriculum will
include brief courses in study design and analytic approaches, best practices and ethics in research, and
career development. Trainees will participate in the workshops, seminars, and research training opportunities
at Northwestern and at relevant surgical and oncologic professional societies. Trainees will design and execute
research projects that culminate in presentations at major national professional meetings and publications in
high-impact journals. Continuous monitoring and iterative program improvement will be achieved by
engagement of a highly accomplished External Advisory Committee and robust evaluation by Northwestern's
Searle Center for Advanced Learning and Teaching. The ultimate goal of the SMART program is to assure an
increase in the number of surgical resident trainees who successfully pursue and achieve academic careers as
independently funded surgical oncologic physician-scientists. Northwestern is uniquely positioned to assure the
success of the SMART program. SMART will be a national leader in developing future surgical oncology
physician-scientist leaders and mentors.

Public health relevance
NARRATIVE We propose the development of the Surgical Multidisciplinary Access to Research in Residency Training (SMART) program to develop the next generation of surgical oncology physician scientists. SMART is anchored by the Northwestern University Department of Surgery's successful history of two-year dedicated research training for residents, by a highly accomplished team of Northwestern researchers and clinicians to provide tailored-mentoring for the residents, and by the unique >15-year partnership in training surgical research residents in conjunction with the American College of Surgeons' Cancer Programs. SMART will be a national leader in increasing the pipeline of qualified surgical oncology physician scientists who go on to faculty positions, with independently funded research agendas, making seminal contributions to the field, and mentoring their own trainees, while also delivering high-quality, compassionate care to cancer patients.